Experimental-data-based in-silico data generation platform to improve the accuracy and reliability of single-cell and spatial omics data analysis

Project Summary
This project aims to develop a suite of advanced yet practical statistical tools with user-friendly interfaces to
enhance the reliability and power of single-cell and spatial omics data analysis through experimental-data-
based in silico data generation. Aim 1 focuses on developing statistical methods to generate in silico data that
serve as negative controls and pseudo-replicates of experimental data. These digital alternatives will help
uncover potential biases and variability in analysis results, which have become more common given the
increasing complexity of single-cell and spatial omics data analysis. In silico negative controls and pseudo-
replicates will enable sanity checks, bias correction, and variability analysis, addressing challenges such as
double dipping, small sample sizes, and data sparsity. Aim 2 involves creating a power analysis suite
leveraging experimental-data-based in silico data generation, covering multi-condition comparisons, temporal
data analysis, and population-scale molecular quantitative trait loci analysis, with the goal of assisting
experimental design considering the high cost of single-cell and spatial omics technologies. Aim 3 will develop
interactive, modularized software packages with a website interface for the single-cell and spatial omics
community to perform experimental-data-based in silico data generation. The software will integrate with state-
of-the-art pipelines like R's Seurat and Python's Scanpy, enabling researchers to easily generate in silico data
from experimental data and enhance the reproducibility of common analysis tasks in single-cell and spatial
omics studies. Overall, this project will provide a new angle to extend the capabilities of computational genomic
research, fostering more accurate and reproducible data-driven discoveries.

Public health relevance
PROJECT NARRATIVE This project aims to develop scDesigner, a computational platform that enhances the reliability and power of single-cell and spatial omics data analyses. By generating in silico datasets tailored to specific analysis tasks, scDesigner will enable researchers to identify and mitigate spurious discoveries, perform robust power analyses, and optimize experimental designs. This work addresses critical challenges in computational genomics, ultimately advancing our understanding of cellular and spatial mechanisms in health and disease and fostering more reproducible and impactful discoveries in biomedical research.